METHADONE DISPOSITION IN MAINTENANCE PATIENTS WITH AND WITHOUT LIVER DISEASE

Studies are being carried out in stable methadone maintenance patients to determine whether or not liver disease varying types and degree of severity determine whether or not liver disease varying types and degree of severity will subsequently alter disposition of methadone in maintenance patients. Stable isotope as well as radioisotope tracer methods are being used in this work.